Adminstrative Core

Project Summary (Administrative Core)
The overall objective of the Administrative Core is to provide leadership, guidance and efficient operation and
management of the Oklahoma COBRE in Structural Biology (OCSB). For this we have developed effective
oversight, fiscal responsibility and transparent administrative policies. The PI/PD, Dr. West, will direct the
Administrative Core and is responsible for all administrative, financial and reporting functions of the OCSB.
She will be assisted by the Associate Program Director Dr. Gillian Air, the Scientific Program Coordinator Dr.
Janiak-Spens, and a full-time administrative staff assistant who will help manage financial, scientific and
communication aspects of the center. An outstanding team of advisors (Steering Committee, IAC, EAC) and
mentors will monitor and guide the progress of the pilot project leaders and research core facilities. The
Administrative Core is responsible for coordinating the activities of the OCSB, communication with the
oversight committees, core directors and mentors, preparation of progress reports, management of the pilot
project program, and organization of the external speaker seminar series. The specific aims of the
Administrative Core are to: 1) Oversee programmatic and financial management of the center with input from
stakeholders and advisory committees; 2) Ensure that the scientific cores remain productive and on a path
towards a long-term sustainable future; 3) Administer an effective pilot project program from pre-award to post-
award; and 4) Serve as a nexus for structural biology in the State of Oklahoma through targeted outreach and
educational activities.